Successful Aging in a Time of Wildfires

“Successful Aging in a Time of Wildfires” is a research study designed to examine the effects of
chronic and acute wildfire smoke exposure on the successful aging of community-dwelling older
adults living in California. Over 1.4 million wildfires have occurred in the U.S. since 2000,
burning an average of 7 million acres annually. Emissions from wildfires pose significant threats
to human health, including cardiovascular, respiratory, and neuro-cognitive effects, and are
estimated to cause more than 15,000 fatalities per year. Older adults are particularly vulnerable
to the impact of wildfire emissions, which exacerbate respiratory and cardiac diseases.
However, beyond direct physical health effects it remains unclear how sociodemographic
factors shape older adult exposure to wildfire smoke and how this exposure subsequently
impacts the functional, cognitive, and socio-behavioral aspects of successful aging. As
California is at particularly heightened risk of wildfires, this study will recruit a racially and
ethnically diverse longitudinal cohort of 1,000 community-dwelling older adults from California
and apply a hierarchical socio-ecological model to the question of whether exposure to wildfire
emissions affects the successful aging of older adults. The strategy reflects a multidisciplinary
approach in which the researchers measure and model ambient toxins in both outdoor and
indoor air; collect and assess epigenetic changes in older adults’ exosomes; and evaluate the
social, psychological, and behavioral factors that moderate the environmental and biological
exposure factors and their impact on successful aging. The broad long-term objectives of the
study are to identify those factors amenable to prevention, mitigation, or adaptation, so that
older adults living in wildfire-susceptible regions of the country can safeguard their health by
attending to the air around them, the buildings in which they live, and to the social supports and
protective behaviors in which they can engage. The research study has four specific research
aims: (1) to develop a California-based observational cohort of older adults with various levels of
wildfire exposure from 2002-present; (2) to estimate outdoor and indoor exposure to chemically-
explicit wildfire emissions among cohort participants; (3) to analyze saliva samples to identify
epigenetic markers of wildfire-exposure, and analyze their association with inflammatory
processes and functional impacts on neurological, cardiovascular, and respiratory systems; and
(4) to develop and test an ecological model for successful aging in older adults exposed to
wildfire emissions that integrates exposure and behavioral data to determine the relationship
between wildfire smoke exposure and successful aging outcomes.

Public health relevance
PROJECT NARRATIVE As disasters such as wildfires increase, older adults are particularly susceptible to the health effects of smoke exposure. By applying sophisticated outdoor and indoor air modeling to estimate older adults’ exposure, and epigenetic assessments to quantify the biological changes related to such exposures, this study will contribute to a greater understanding of the dose- response relationship between wildfires and successful aging among older adults. Furthermore, this study will help establish the ways that socio-behavioral factors moderate this dose-response relationship to promote or inhibit successful aging among older adults.